Career Enhancement Program

PROJECT SUMMARY/ABSTRACT
The SPORE Career Enhancement Program (CEP) prepares physicians and scientists for independent careers
as investigators in translational research in prostate cancer. We have designed the CEP to form both an
interdepartmental and an interinstitutional training ground to produce investigators who will become intellectual
leaders in their fields of interest. By combining the research and academic resources available throughout
Memorial Sloan Kettering Cancer Center and at our affiliated institutions, we have a long tradition of successful
faculty development. Recruiting and/or developing the career of junior faculty members committed to
translational research in prostate cancer is a centerpiece of our program. Over the next 5 years we will
continue to recruit and develop the careers of junior faculty members and experienced investigators—from
both basic research and clinical backgrounds—committed to translational research in prostate cancer.